Lymphatic drainage dysfunction in chronic hypertension

Abstract
Malfunction of the brain’s waste clearing glymphatic system has been shown to play a key role in cerebral small
vessel disease the most common cause of vascular cognitive impairment prevalent with chronic hypertension in
the aging population. Cerebral small vessel disease (cSVD) affects 750 million people worldwide, causes up to
45% of all dementias, and accounts for ~20% of all stroke cases, yet the underlying pathophysiology - even in
the setting of hypertension - remains incompletely understood. Remarkably, the status of the lymphatic system
(LS) has not been investigated in cSVD. We have novel data showing functional impairment of the LS a cSVD
rat model with chronic hypertension (spontaneously hypertensive stroke prone (SHRSP) rat strain). Here we
posit the entirely novel idea that alterations of the lymphatic system including meningeal lymphatics and lymph
nodes draining brain waste in the setting of chronic hypertension contribute to cSVD. Specifically, we will test
the main hypotheses that, cSVD with chronic hypertension is associated with uncoupling of the glymphatic and
lymphatic systems and that systemic impairment of lymphatic drainage contributes to the pathogenesis of cSVD.
We will apply our novel imaging approaches and computational analysis tools to characterize lymphatic drainage
concurrently with glymphatic transport in a comprehensive series of experiments involving SHRSP rats with
normotensive Wistar Kyoto (WKY) rats serving as controls. In Aim 1, we will determine the role of hypertension
on glymphatic-lymphatic coupling. Lymphatic system function will be measured concurrently with glymphatic
transport in untreated SHRSP rats and in SHRSP rats treated with antihypertensive medication (amlodipine) to
reduce small vessel pathology at the whole-body level. We hypothesize that decreased glymphatic transport in
SHRSP rats with chronic hypertension will be associated with glymphatic-lymphatic uncoupling. Furthermore,
we expect amlodipine treatment will restore LS function in SHRSP rats. In Aim 2, we hypothesize that the
pathogenesis of cSVD with chronic hypertension may be caused by a defect in lymphatic drainage that impairs
glymphatic waste clearance over time. This assumption will be tested by gain-of-function (increasing the
lymphatic vasculature with Vascular Endothelial Growth Factor C (VEGF-C)) and loss-of-lymphatic drainage
(blocking drainage to the dcLN) experiments. In Aim 3 the goal is to generate a molecular and biochemical
platform which will drive the understanding of which changes in the lymphatic system are associated with chronic
hypertension. We will first conduct a comprehensive “omic” analysis of the CSF collected from WKY and SHRSP
rats in Aims 1 & 2, since our scientific premises indicate that CSF is a reliable mirror of the ongoing brain
activities. Next, we will move towards the anatomical, cellular and biochemical characterization of the lymphatics
draining to the deep cervical node, since preliminary studies indicate that collagen deposits are associated with
increased blood pressure. Molecular pathways that we identify can later be probed for therapeutic benefit.

Public health relevance
Project Narrative Malfunction of the brain’s waste clearing glymphatic system has been shown to play a key role in cerebral small vessel disease (cSVD) the most common cause of cognitive impairment with chronic hypertension. Remarkably, the status of the lymphatic system (LS) has not been investigated in cSVD. We have novel data showing functional impairment of the LS in chronic hypertension and here we explore the novel idea that these pathological alterations contributes to cSVD.